TYK2 Fusions in Lymphoma

PROJECT SUMMARY
Malignant lymphomas are a leading cause of cancer death ranking 6th among malignancies resulting in mortality.
Among these, mature T-cell lymphomas often exhibit an aggressive clinical course and their pathogenesis is
poorly understood. ALK-negative anaplastic large cell lymphoma (ALK-negative ALCL) represents a poorly
understood category of mature T-cell lymphomas. Unlike other hematopoietic malignancies, recurrent genetic
alterations that have been exploited as rational therapeutic targets have not been described in these tumors. We
discovered for the first time, recurrent translocations targeting the intracellular tyrosine kinase TYK2 in ALK-
negative ALCL. In this regard, we identified a gene fusion juxtaposing the nucleophosmin (NPM1) gene (5q35)
to the TYK2 gene (19p13). NPM1 is a nucleolar phosphoprotein involved in several oncogenic gene fusions and
mutations in cancers. Notably, TYK2 was the first member of the Janus activating kinase (JAK) family described
and propagates physiologic cytokine-driven signals and is critical for T-cell proliferation and differentiation. The
signaling networks by which the NPM1::TYK2 fusion promotes lymphomagenesis are unknown. Based on our
preliminary data, it is our central hypothesis that NPM1::TYK2 is an oncogenic driver that promotes the
development of TCL, and that the kinase activity of NPM1::TYK2 is required for its oncogenicity. Our preliminary
results demonstrate that expression of the recurrent NPM1::TYK2 fusion in conditional transgenic mice induces
lymphomas that recapitulate the morphologic and genetic features of TCL, specifically ALCL. Thus, the main
goal of this proposal is to investigate the in vivo oncogenicity of NPM1::TYK2 and the pathways of NPM1::TYK2-
induced lymphomagenesis. The overall impact of this proposal is to advance understanding of the mechanisms
by which oncogenic TYK2 causes lymphoma and identify currently unknown downstream signaling modules
which may serve as vulnerability targets for novel precision therapy for oncogenic TYK2-driven cancers.

Public health relevance
PROJECT NARRATIVE We propose to investigate the oncogenicity and signaling consequences of expression of a genetic abnormality affecting a gene known as TYK2, a cancer driver gene discovered to be recurrently altered in human T-cell lymphomas. Our studies will also investigate the possibility that oncogenic TYK2 and its downstream signaling modules may be precision therapeutic targets in these cancers.